Antecedent Biomarkers for Alzheimer Disease: The Adult Children Study

Overall: Project Summary/Abstract
“Antecedent Biomarkers for Alzheimer Disease: The Adult Children Study” (ACS) will determine when during
the lifespan molecular markers of Alzheimer disease (AD) appear in the brain of cognitively normal, largely
middle-age individuals and also will characterize the course of preclinical AD. With maturation of the original
ACS cohort, we now will identify the factors that mediate the transition from preclinical AD to symptomatic AD
(the latter term in this application is used to encompass both mild cognitive impairment due to AD and AD
dementia). This renewal application examines the hypothesis that disrupted neural integrity predicts the
transition from preclinical to symptomatic AD and thus proposes four Cores (Administration, Clinical, Fluid
Biomarker, and Data Management and Biostatistics) to support four Projects: Project 1 (JC Morris and T
Benzinger, Co-Project Leaders), “Tau burden and spatial spread in preclinical Alzheimer disease”; Project 2
(AM Fagan, PL), “Plasma and cerebrospinal fluid (CSF) biomarkers that predict risk for symptomatic Alzheimer
disease”; Project 3 (B Ances, PL), “Alzheimer disease progression, host gut microbiome, and enteric
dysfunction”; and Project 4 (D Head, PL), “Mechanisms and moderators of the effects of physical activity in
preclinical AD”. Although these Cores and Projects each address unique Specific Aims, they will generate a
wealth of cross-sectional and longitudinal data from ACS participants to permit a cohesive and comprehensive
examination of the overarching Aims of this renewal application. Hence, the ACS as a whole is far greater
than the sum of its Cores and Projects.

Public health relevance
Overall: Project Narrative The Adult Children Study has created a cohort of middle age and older individuals, with and without a parental history of Alzheimer disease (AD), who longitudinally undergo a comprehensive battery of biological, clinical, and cognitive tests to identify the earliest brain changes of AD prior to any clinical symptoms. Our hypothesis is that the compromise of neuronal function by these brain changes predicts the transition from preclinical AD to symptomatic AD. This renewal will focus on the factors that accelerate or prevent development of symptomatic disease.